Trigeminal nerve-target tissue interactions during craniofacial development

PROJECT SUMMARY
Proper formation of the head and face involves coordination of interactions among multiple tissues, including the
cranial nerves and mesenchyme, with aberrant interactions leading to cranio- and/or orofacial anomalies. These
abnormalities account for one-third of all birth defects, place a substantial financial burden on our healthcare
system, and are the primary cause of infant mortality. Thus, a comprehensive understanding of craniofacial
development that incorporates nerve-tissue interactions in a holistic approach is essential to overcome the
current challenges in treatment of diseases and disorders affecting the head and face. Many cranial nerves
transmit somatosensory information and possess neuronal cell bodies and glia within cranial ganglia, which arise
from the coalescence and differentiation of neural crest cells (NCCs) and placode cells (PCs). The appearance
of these ganglia, and the nerves to which they contribute, typically precedes that of their target tissues, strongly
implicating innervation in the context of target development. Notably, the trigeminal ganglion (TG) mediates the
majority of facial sensations due to its association with cranial nerve V, which is uniquely positioned in the head
to influence cranial cartilage and bone development due to the tissues through which it traverses. Prior studies,
including work by our lab, have shown the importance of NGF/TrkA signaling in TG axon outgrowth and target
tissue innervation. Intriguingly, this pathway has also been implicated in trunk long bone development,
maintenance, and repair, but this function for NGF/TrkA signaling has not been explored in the context of cranial
cartilage and bone development. Moreover, our new studies reveal remarkable deficits in cranial bone upon
perturbation of the PC component of the TG, a cell type that does not make this tissue, further underscoring the
importance of nerve-tissue interactions during development. However, the processes by which TG innervation
actively orchestrates target development and maintenance remain a significant gap in our knowledge of
craniofacial development. Herein, we will interrogate how unique nerve (TG)-target tissue (cranial mesenchyme)
interactions are required for the TG and its nerves to direct cranial cartilage and bone development through
pioneering studies in the chick embryo in the following Specific Aims: 1) determine the role of NGF/TrkA
signaling in embryonic cranial cartilage and bone development and 2) define how TG innervation directs target
tissues to form cartilage and bone. Our proposed research is innovative because it employs a systems-level,
multidisciplinary approach involving embryology, molecular cell biology, and transcriptomics, with the goal of
generating a new model to study nerve-target tissue interactions. These results will significantly advance our
knowledge of the molecular mechanisms underscoring TG nerve-tissue interactions directing formation of the
head, and, collectively, the etiology and therapeutic treatment of cranial nerve disorders and diseases arising
from aberrant NCC and PC development.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because of the biological significance and contribution of neural crest and placode cells to the proper formation of human bodies, including the development of the peripheral nervous system like the trigeminal ganglion, bones and cartilage of the face, skin pigment cells, and parts of the heart. How these cells contribute to these diverse structures and generate these different cell types can help us comprehend what happens when development is impaired and human disease ensues. Thus, the proposed research is directly relevant to NIH’s mission to understand the fundamental processes controlling development and the use of that knowledge to improve overall human health and quality of life.